Minnesota Department of Agriculture AFRPS Maintenance Track

Project Abstract
The intended outcome of this project is to strengthen and enhance integration of state and federal
animal food regulatory systems through continued support of the Animal Food Regulatory Program
Standards.
The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD) licenses and
inspects approximately 1,900 feed entities manufacturing, distributing, and guaranteeing feed or feed
ingredients in Minnesota. The FFSD has program responsibility for animal feed and pet food and has a
staff complement of 17 for feed-related activities with seven devoted to field inspection and three
assigned to pet food labeling, product investigation and distribution. The MDA-FFSD also has multiple
supporting units that include an additional 20 staff who fully or partially assist the Commercial Feed
Program in day-to-day operations including compliance and enforcement, response and outreach, data
management, training support, and electronic systems maintenance. These staff also lead and
coordinate updates to procedures and processes including document management as well as achieving
and maintaining conformance with the AFRPS.
The MDA, as part of this application, will create a comprehensive project plan that outlines the
objectives and deliverables needed to maintain conformance with AFRPS.

Public health relevance
Project Narrative The Minnesota Department of Agriculture seeks to maintain conformance with AFRPS and the requirements of the FDA State Contract Audit Program. MDA will continue to improve data submission for inspection reporting and inventory information through sharing and jointly managing facility info, maintain regular meetings with FDA personnel, and submit reporting as required to support an Integrated Food Safety System.